Ultrasensitive detection of Mycobacterium tuberculosis infection

PROJECT SUMMARY
Tuberculosis (TB) afflicts nearly one-third of the world’s population, but progress in development of
interventions is hamstrung by the slow growth rate of Mycobacterium tuberculosis (Mtb), the causative agent,
and the need to evaluate viability by colony forming units (cfu). We plan to overcome this roadblock through
development and validation of imaging technologies that can be broadly applied to all TB research. Our
studies have produced new imaging technologies for TB, with the most sensitive having a threshold of ~103
cfu during pulmonary infection. Imaging allows therapeutic evaluation within hours, rather than weeks, both
in vitro and in animals, but improved sensitivity would have a transformative effect on the TB field. We have
demonstrated the ability of imaging to quantify and track infection in nearly any tissue if the bacteria are at
high enough levels, but the thresholds of detection have not been low enough to ensure relevant infectious
doses can be detected in deep tissues. The proposed project would significantly increase sensitivity, offering
the unique opportunity to track infection, vaccines, therapeutics and challenge doses for Mtb in real-time at
physiologically relevant bacterial numbers. We will build upon our earlier studies by improving and validating
the ability of REF imaging to sensitively track the bacteria, evaluate efficacy of therapeutics, determine
bacterial loads in nearly any tissue and the ability to rapidly determine vaccine efficacy. Specifically, we
propose to: 1) Develop new imaging technologies for Mtb. Our working hypothesis is that optimized
imaging technologies can allow detection of single bacteria in vitro and in vivo. Our preliminary data
demonstrated that we can improve imaging sensitivity and specificity through modifications of REF and SREL
substrates and application of microendoscopy. In this aim we will examine novel substrates and modified
microendoscopy systems for improving the threshold of detection and monitoring Mtb in vitro and in vivo. 2)
Improve imaging technologies to transform Mtb pathogenesis studies. Our working hypothesis is that
the ability of imaging to track Mtb in all organs during infections will give new insight into pathogenesis. Our
preliminary data suggest imaging with new reporters (NanoLuc/NanoBRET) could allow more sensitive
localization during dissemination from the lungs. In this aim we will validate these observations by quantifying
bacteria in lungs and other organs by imaging, validate dissemination and analysis of our existing mutants.
3) Facilitate therapeutic analysis and vaccine efficacy using imaging. Our working hypothesis is that
imaging will allow us to evaluate TB therapeutics and vaccines more rapidly. Our preliminary studies suggest
that new probes, markers and microendoscopy systems can be used to follow vaccines, challenge doses and
impact of therapeutics by imaging, providing immediate feedback on efficacy of new treatments. In this aim
we will utilize reporter vaccines and Mtb strains to analyze vaccines and therapeutics in mice to more rapidly
evaluate efficacy and compare the data obtained to conventional methods.

Public health relevance
Project Narrative Tuberculosis represents one of the most frequent causes of morbidity and mortality in humans worldwide. Tuberculosis drug resistant infections are increasing throughout the world, making it critical that rapid screening strategies are developed for therapeutics and other novel interventions. This project is geared toward improvement and validation of groundbreaking imaging technologies that can be used to replace much slower and inefficient conventional approaches to track bacterial viability, whole animal localization during disease and speed development of novel therapeutics and vaccines.